Technical and Logistical Support for Cancer Surveillance

The overall objective of this Task Order is to work with the National Cancer Institute (NCI), Division of Cancer Control and Population Sciences (DCCPS), to support for developing web-based interactive public Project Interface Systems for specific consortium projects and publications. These interfaces shall help the general research community to better understand a project and allow users to explore the responses to inputs.